Exploring the angiogenesis-to-fibrosis transition in ischemic retinopathies Renewal

Diabetic retinopathy (DR) and other forms of retinal ischemia are a leading cause of blindness in
working age adults. There is a need to identify the mechanisms underlying the transition from
angiogenesis to fibrosis in these conditions, as a first step towards new therapies to address
progressive retinal vascular damage that ultimately leads to pre-retinal fibrosis and traction
detachment with poor visual and anatomic outcomes.
To address this gap in our knowledge, we have designed a series of experiments that build
logically on our preliminary data which shows robust evidence for pericyte involvement in
fibrovascular tissues, and the potential markers. We have optimized the timepoints for
examining their role in a mouse model of ischemia induced retinal fibrosis and optimized the
relevant fate tracing transgenic mouse.
To examine this hypothesis, we will study animal models that focus on developmental ischemia-
the oxygen induced retinopathy (OIR, to replicate angiogenesis in ischemia) and the limited
hyperoxia-induced proliferative retinopathy (LHIPR), which replicates the angiofibrotic end-
stages of severe ischemia. We will use these models and ground our results in human donor
eye studies, to test the hypothesis that the entire retinal transcriptome and epigenome is
dysregulated during retinal fibrosis and identify targets for therapy. We will use a combination of
single cell, high throughput sequencing and data analysis. We will also examine the fibrosis
effectors directly by using genetic fate tracing. We will then use viral delivery of therapies to
identify molecules that are necessary and sufficient for the transition to retinal fibrosis as these
can be critical targets for human translational applications.
The mechanistic experiments proposed herein will capitalize on the interdisciplinary expertise of
the clinician-scientist PI (Dr. Fawzi) a clinician-scientist retina surgeon with special expertise in
non-invasive retinal imaging, animal models of ischemia and retinal vascular diseases. Her co-
investigator, Dr. Zhu, is a world-class expert in developing advanced tools for viral-mediated
delivery, and Dr. Goyal an expert in analyzing high throughput complex multi-omic dataset. The
strength of the preliminary data and team ensure the success this highly innovative proposal
that addresses an unmet need in our field.

Public health relevance
This proposal aims to study the process of retinal vascular damage that leads to retinal blindness from fibrosis. The experiments use a range of mouse models that replicate the different stages of human disease, as well as human donor eyes, allowing the team to study specific markers that promote scar formation. Success of this proposal will lead to the development of new therapies that can prevent and reverse advanced scar tissue formation in the retina, along with their devastating and blinding complications.